Core C

PROJECT SUMMARY
The Physiology and Surgical Core will provide the infrastructure to facilitate increased productivity and
synergy between the various projects to aid in defining the mechanisms by which exosomes mediate cell-to-
cell communication both within the heart, as well as cross-organ signaling, to regulate pathways involved in
cardiac injury and protection. The Core will not only provide a consistent and reproducible service in support
of the projects but will further participate in experimental design, prioritization of resources, and the
interpretation of data. In addition, Core C will identify additional areas for collaboration across all projects as
the program matures and thus be central to the interactive environment and comprehensive analysis of the
overall platform as data is generated. The core is a critical aspect to the success of the overall program
because it will provide dedicated and highly specialized services to all projects. Perhaps most importantly the
core will eliminate much of the noted variability in surgical techniques and protocol variations and thereby
enable a direct comparison of results across all projects.

Public health relevance
PROJECT NARRATIVE The goal of the Physiology and Surgical Core (Core C) is to support all projects by providing expertise to carry out numerous experimental approaches to examine cardiac physiology and pathology in the intact animal. These services will provide the backbone for the major focus of this Program Project Grant to determine exosome-mediated cell-cell communication both locally within the injured myocardium and distally with other organs and how these intracellular and inter-organ communications influence overall myocardial responses to injury and the repair process. Understanding these very important processes we hope will lead to the development of new treatments for heart disease.